Social and Biological Influences of Sleep in ADRD Spousal Caregivers

ABSTRACT
The parent project aims to understand how social isolation and loneliness affect caregiver burden and the
momentary role of loneliness in physical health outcomes, as well as identify temporal targets for intervention
based on momentary loneliness in ADRD spousal caregivers. We will examine how vagally mediated HRV
impacts mental and physical well-being in ADRD spousal caregivers as an exploratory aim. Three Hundred
ADRD spousal caregivers will complete assessments on attachment, quality of life, caregiver burden, grief
symptoms and participate in a blood draw to evaluate inflammation and indices of cellular aging (i.e.,
mitochondrial and glycolytic function). These caregivers will also complete momentary assessments of
depressive affect, loneliness, and social isolation, and we will continually measure vagally mediated HRV over
two weeks. Based on Houston’s demographics and the recruitment approach in our parent grant, we plan to
enroll 150 Latinos.
This study plans to investigate sleep health in ADRD spousal caregivers, considering social and biological
factors. There is a recognized disparity in sleep health between ADRD caregivers and non-caregivers, with
evidence suggesting that poor quality sleep is associated with reduced cognitive and physical functioning and
increased risk for physical and psychological morbidity in this group. Poor sleep quality has also been
associated with mitochondrial dysfunction and cellular aging processes. Chronic stress from childhood
economic disadvantage has been linked to dysregulated biological and psychological stress and sleep processes,
and poorer physical and mental health outcomes in adulthood. We predict that caregivers with poorer sleep
quality will present with increased mitochondrial dysfunction and poorer self-reported health. We also predict
that spousal caregivers who report lower childhood SES will report poorer sleep quality than spousal caregivers
with higher childhood SES. For our exploratory aim, we predict that for caregivers who report lower childhood
SES, the relationships between poorer sleep quality, mitochondrial dysfunction, and poorer self-reported health
will be stronger than for caregivers with higher childhood SES. Investigating the role of sleep health in cellular
function and overall self-reported health can help to inform interventions to improve caregivers’ sleep,
wellbeing, and disease outcomes. Also, recognizing disparities based on childhood socioeconomic status can
help to identify caregivers who may be at increased risk for health impacts as a result of the caregiving
experience.

Public health relevance
PROJECT NARRATIVE Our objective with this proposal is to examine sleep health in ADRD spousal caregivers, considering how sleep quality is related to social and biological factors. By investigating the mechanisms underlying sleep health disparities among ADRD caregivers, we may be able to identify caregivers at increased risk for physical and psychological health impacts. We can also better understand physiologically how sleep and psychosocial factors interact with mitochondrial functioning and cellular aging.